Describing Down Syndrome: Genetic Counselors'Attitudes

The goal of this study is to describe how prenatal genetic counselors explain Down syndrome to their clients as well as to document prenatal genetic counselors' attitudes about Down syndrome and their personal experience with people with developmental disabilities. Relationships between counselors' attitudes, expereinces and description of Down syndrome will be explored. The specific aims are to: 1. To describe the type of personal experience prenatal genetic counselors have with people with developmental disabilities. 2. To describe counselors' attitudes toward Down syndrome. 3. To describe the components of the